A Neuron-specific Methyl-histone Regulatory Complex

Project Summary
This project aims to unravel the unique chromatin regulation mechanisms in neurons and their role in
neurodevelopmental disorders. Mutations in chromatin regulators are frequent causes of neurodevelopmental
disorders such as intellectual disabilities, autism, and schizophrenia. The abundance of chromatin regulator
mutations poses a question: why is the brain so vulnerable to chromatin dysregulation? The molecular basis of
this vulnerability remains elusive, which prevents the understanding of the etiology of neurodevelopmental
disorders.
Our previous work identified 14 chromatin regulator genes undergoing neuron-specific mRNA splicing,
including LSD1 and PHF21A, which form a complex within neurons. We discovered that neuronal splicing
events in LSD1 and PHF21A impair nucleosome binding and reduce H3K4 demethylation activity. The
neuronal PHF21A variant prevents excessive synapse formation. Building on these findings, we propose to
investigate:
1. The recruitment of the neuronal LSD1-PHF21A complex by MYT1L, a neuron-specific transcription
factor, to regulate gene expression during neuronal maturation.
2. The interplay between non-CpG methylation and the neuronal LSD1-PHF21A complex in regulating
gene promoters.
3. The structural and functional differences between canonical and neuronal LSD1-PHF21A complexes,
focusing on the role of HMG-box DNA binding proteins BRAF35 and iBRAF.
Our research will employ biochemistry, functional genomics, neuronal morphological analyses, genome-wide
methylation analysis, and structural biology techniques. We expect to gain insights into how neuronal splicing
of broadly expressed chromatin factors cooperates with neuron-specific chromatin regulators and transcription
factors. This study is expected to improve our understanding of neuron-specific chromatin regulation and its
implications in neurodevelopmental disorders, potentially leading to new therapeutic strategies for conditions
associated with chromatin dysregulation in the brain.

Public health relevance
Project Narrative This project investigates how chromatin regulatory mechanisms unique to the brain contribute to neurodevelopmental disorders. The team will study specific chromatin regulator genes that undergo neuron- specific structural changes. The findings could lead to new treatments for conditions like intellectual disabilities, autism, and schizophrenia by improving our understanding of how genetic information is utilized in neurons.